Administrative Core

Administrative Core
The Administrative Core includes the four PIs, Drs. Ahles and Gany (MSK) and Drs. Espinosa and Vuong (CCNY), Research Education Core Leaders Dr. Heller (MSK), with Drs. Espinosa and Vuong; Partnership Community Outreach, Research, and Education/Engagement Core (PCORE) Leaders Dr. Leng (MSK), and Dr. Lubetkin (CCNY); LinguistiC Shared Resource Core (LCRSRC) Leaders Drs. Gany and Diamond (MSK) and Drs. Riobó, Uyar, and Wei (CCNY), and the Administrative Core staff, from both CCNY and MSKCC. The U54 Administrative Core coordinates all Partnership activities and ensures that the Partnership continues to function effectively and efficiently. Specifically, the Administrative Core will: 1) coordinate biweekly meetings of Partnership PIs; quarterly meetings of the Administrative Committee (which includes the leaders of the REC, LCRSRC, and PCORE); quarterly Planning and Evaluation (PEC) (including Working Groups) and Internal Advisory Committee (IAC) meetings; annual Program Steering Committee (PSC) meeting, and any ad hoc meetings; 2) meet with the Executive Committee on an annual basis to evaluate the potential synergy between Partnership goals and new institutional initiatives, including recruitment of new faculty; 3) provide support for both institutions’ research resources and facilities and to provide access to and awareness of these resources for Partnership investigators, faculty, and students; 4) support the Research Education Core (REC) with student placements at either CCNY or MSK in research laboratories or service-based learning projects and to provide administrative support for faculty that teach in Partnership courses; 5) in collaboration with the Planning and Evaluation Core, ensure ongoing planning, monitoring, evaluation and tracking of Partnership activities, including fiscal planning and management for all aspects of the Partnership and the distribution of developmental funds, and strategic planning, including in an annual Strategic Planning Retreat; and 6) maintain and update a manual of Standard Operating Procedures.